Enhancing Data Science Skills Through Bio-OCS - Biomedical Open Case Studies

Project Summary/Abstract
Dramatic advances in artificial intelligence, single cell sequencing, spatial transcriptomics, and temporal data
hold great potential for propelling biomedical understanding forward. However, access to training for these
cutting-edge emerging technologies and data science best practices remains limited, particularly for
researchers and trainees at under-resourced institutions. Furthermore, researchers often struggle to find time
to apply newly acquired skills to real-world data in a research context. To address these challenges, we
propose expanding the Open Case Study (OCS) project to create Biomedical OCS (Bio-OCS), a comprehensive
skills development program augmented by synchronous events and community support for research scientists
and trainees. This initiative will focus on building bioinformatics skills using cutting-edge methodologies and
tools, like AI and spatial transcriptomics, as the basis for case studies. Case studies demonstrating applications
with real-world data have proven useful for teaching statistical thinking; the OCS project takes this model
further by providing a free archive of case studies, guiding learners in working with data from start to finish
and allowing them to demonstrate the necessary computational and problem-solving skills. To support uptake
of these skills, the Bio-OCS program will also include virtual workshops for learners to work through our case
studies with peers, launch a Slack workspace to facilitate a peer community, hold office hours and check-ins to
assist in problem solving, and host in-person “Case-A-Thons” to support the application of case study lessons
to participants' own data. Additionally, we will collaboratively adapt our current OCS Instructor Guide by
hosting Reciprocal Instructor Summits where we convene instructors from a diverse set of institutions and
communities. The new case studies, coupled with the supporting workshops, events, and resources, will
enable us to better support diverse learner communities in building biomedical skills. Lessons learned through
evaluation of our events and from Bio-OCS learner survey responses will be published in research papers to
further support biomedical data science education.

Public health relevance
Project Narrative To address the gap in data science skills development for biomedical researchers due to rapid technological advances, we propose Biomedical Open Case Studies (Bio-OCS), a comprehensive experiential education program centered around data analysis case studies. Learners will use real biomedical data to understand emerging computational technologies and best practices through the online case studies, guided hands-on workshops, in-person collaborative events, and community dialogue. This scalable program, with its emphasis on peer community support and learning, will help researchers take full advantage of cutting-edge technologies and practices (such as AI and other emerging methods) to further enhance their research.